Genetic and Immunological Control for Development of Asymptomatic Malaria

Abstract
Malaria is a significant problem in endemic areas with approximately 3 billion people at risk and over 200
million clinical cases resulting in between 0.4 and 0.5 million deaths. However, the majority of the population in
malaria endemic areas (>60%) is asymptomatic (without overt symptoms), even in high transmission areas.
Although identified by circulating Plasmodium-infected red blood cells (iRBCs) in the circulation, the term
asymptomatic malaria is a misnomer with individuals experiencing mild anemia and vascular activation,
susceptible to co-morbidities such as non-typhoidal Salmonella infections, and acting as a reservoir for
infection. Assumed to be controlled by adaptive immunity that builds over several years, this is unlikely to be
the case in young children under the age of 2 who have asymptomatic malaria. The long-term goal of this
project is to define the genetic and immunological mechanisms that confer asymptomatic malaria in young
children before the onset of robust adaptive immunity. Our overarching hypothesis is that genetic variation
leading to differential innate immune responses is responsible for controlling asymptomatic malaria. The
immunological and genetic underpinnings governing asymptomatic malaria is unknown - there is no genetically
intact rodent model to dissect the contributions of allelic variation and individual immunological components.
Our working hypothesis is that the collaborative cross (CC) mouse lines, upon infection with Plasmodium yoelii
XNL, model human genetic variation to allow identification of QTL associated with the development of mild
anemia, a trait associated with asymptomatic malaria in humans. Our preliminary data using specific pathogen
free (SPF) wild-caught genetically variable Mus musculus domesticus show a wide variation in anemia and
innate immune responsiveness after Plasmodium infection demonstrating that genetic variation in mice could
be harnessed to identify the immunological mechanisms associated with asymptomatic malaria. Guided by this
preliminary data, the work proposed will be undertaken under a single specific aim: Phenotype 38 CC mouse
lines to identify QTLs that govern the level of anemia and innate immune responsiveness to
Plasmodium infection. Three sub-aims will 1) determine which CC mouse lines develop asymptomatic
malaria 2) begin to map QTLs and identify gene candidates that are associated with development of
asymptomatic malaria in mice 3) test the hypothesis that asymptomatic malaria is associated with a robust
innate immune response. Once completed, the proposed work is expected to identify key QTLs underlying
malarial anemia in mice and discover gene candidates and genetic networks associated with asymptomatic
malaria. The proposed research is significant because by identifying the lines that display limited anemia upon
P. yoelii XNL infection we will now provide, for the first time, a genetically intact rodent model which can be
used to understand how asymptomatic malaria is genetically and immunologically controlled. This will include
as how asymptomatic malaria influences co-infecting pathogens and efficacy of childhood vaccines.

Public health relevance
Project narrative The proposed research is relevant to public health because we will use the mouse model of asymptomatic malaria developed here to determine genetic and immunological factors that mediate asymptomatic malaria in young children prior to the development of adaptive immunity. This is important because it sets the stage for further studies aimed at defining the subsequent events that lead to conversion to symptomatic malaria as well as non-malaria co-morbidities such as non-typhoidal Salmonella infections that are associated with asymptomatic malaria. Thus, the proposed research is relevant to the NIH’s mission that pertains to developing fundamental knowledge that will help to reduce the burdens of human disease and disability.